Converting cytoskeletal forces into biochemical signals

PROJECT SUMMARY
Cells perceive mechanical cues in their local environments, which must be converted into intracellular
biochemical signals to modulate cellular physiology and control gene expression. There is increasing
appreciation for mechanical signal transduction’s (“mechanotransduction”) critical role in development and its
dysfunction in disease states such as cancer. However, in contrast to canonical signal transduction, cellular force
sensing is poorly understood, hampering efforts to define mechanistically distinct mechanotransduction
pathways, delineate their specific biological functions, and target them therapeutically.
The actin cytoskeleton, a network of dynamic actin filaments, myosin motor proteins, and hundreds of
associated factors, enables cells to mechanically interface with their surroundings. The cytoskeleton is classically
understood to serve as a force generation and transmission apparatus that indirectly facilitates mechano-
transduction through its physical linkages to membrane-anchored sites which mediate force signal conversion
(e.g. cell-cell and cell-matrix adhesions). However, we and others have recently reported direct binding of soluble
cytosolic proteins containing tandem arrays of LIM (LIN-11, Isl-1 & Mec-3) domains to tensed actin filaments,
suggesting that the cytoskeleton itself may have the capacity to transduce forces into biochemical signals. Here
I propose to test the hypothesis that force-activated actin binding by distinct LIM proteins is upstream of
functionally discrete downstream mechanotransduction pathways. Through cellular assays and biophysical
reconstitution, we will investigate how the representative force-activated actin binding LIM proteins zyxin (Aim 1)
and FHL1/2 (Four-and-a-Half LIM domains 1/2, Aim 2) mediate distinct downstream functions in cytoplasmic
cytoskeletal damage repair and nuclear gene expression regulation, respectively. We will then innovatively
interface these approaches with cryo-electron microscopy (cryo-EM) to visualize force-activated actin binding by
LIM proteins in structural detail (Aim 3). Our studies will establish how a conserved mechanism of force
transduction through LIM domains is linked to distinct downstream signaling outcomes, which is likely to reveal
general principles underlying the modular organization of cytoskeletal mechanical signaling networks. In the
longer term, this work will enable precision dissection of context-specific biological functions of LIM proteins in
vivo, facilitating rigorous evaluation of their potential as therapeutic targets.

Public health relevance
PROJECT NARRATIVE The ability of cells to perceive mechanical cues is critical for development, tissue homeostasis, and immune function, and is dysregulated in disease states including cancer and muscular dystrophies. This project aims to reveal fundamental mechanisms of how forces transmitted through the actin cytoskeleton are converted into biochemical signals which govern cell physiology and regulate gene expression. In the near-term, our studies will enable rigorously determining the specific functions of these pathways, which in the long-term will guide efforts to target them therapeutically.